Neuromodulation of the fear extinction circuit using temporally and anatomically specific TMS in humans

Project Summary
Neuromodulation is becoming the new frontier in psychiatry. Our recent advances in the understanding of
neural circuits involved in fear and its regulation provide us with a well-defined targets and circuits to manipulate
to restore normal functioning. Transcranial magnetic stimulation (TMS) provides a great tool to non-invasively
manipulate such circuits. Despite some great clinical success in TMS and its application to psychiatric
conditions, the mechanisms of how TMS impacts fear circuits are not understood and its parameters currently
employed are not fully optimized. Our objectives are to 1) understand how varying TMS parameters affect
targeted brain regions in order to 2) optimize its impact on enhancing fear extinction memory consolidation in
a population with known fear extinction deficiencies: posttraumatic stress disorder (PTSD). As with all
manipulations, not all participants will respond to TMS and fear reduction induced by TMS will vary across
subjects. An exploratory objective is to develop mathematical models for predicting who will respond to TMS
based on the magnitude of conditioned and unconditioned fear along with clinical and anxiety measures.
Subjects will undergo our well-established fear conditioning and extinction paradigm across 3 days. On day 1,
they will be aversively conditioned to two cues. On day 2, subjects will undergo extinction training where
conditioned cues will be paired with TMS in a temporally and anatomically specific manner. On day 3,
conditioned cues will be presented in the fMRI scanner. The network to be investigated is the fear extinction
circuit: the ventromedial prefrontal cortex (vmPFC), dorsal anterior cingulate cortex (dACC), hippocampus, and
amygdala. Skin conductance response (SCR) will also be measured. We will explore the impact of narrow
TMS timing variance (relative to onset of conditioned fear stimuli) and anatomical location on fear extinction
memory on the activation of fear extinction network. Our target will be the dorsolateral prefrontal cortex (dlPFC)
that is functionally coupled with the vmPFC. Using the principles of response surface methodology (RSM), we
will characterize and establish the effect of temporal and anatomical variations of TMS relative to the
conditioned cue on conditioned fear reduction (aim 1). We will then use the optimized TMS parameters to test
if TMS can restore extinction memory deficit in subjects with PTSD (aim 2). An exploratory aim will be to
develop mathematical models to predict TMS success in obtaining the best outcome on extinction memory
based on SCR and clinical data. Our findings would provide key translational data applying knowledge
gathered from rodents into the human brain and could help us understand the mechanisms of neuromodulation
regarding change in the neural correlates of fear extinction network in PTSD patients.

Public health relevance
Project Narrative The experiments proposed are aimed to understand how timing and location of transcranial magnetic stimulation (TMS) in humans will impact their ability to reduce conditioned fear responses and impact the activation of their brain regions involved in fear regulation. We will use a novel TMS approach to vary timing and location of its delivery so that we can characterize and establish best time and location to obtain optimal impact on fear inhibition, and then test these parameters in PTSD patients and see if such can rescue extinction deficits in PTSD. The anticipated impact is to enhance our understanding of the neural mechanisms of associated with TMS use and explore potential novel approaches for advancing PTSD treatment.